Neuroplasticity-Based Computerized Cognitive Remediation (nCCR) for Treatment Resistant Late-Life Depression

Abstract
This proposal is submitted in response to RFA-MH-18-707 and NOT-MH-20-027, and aims to conduct a
randomized, double-blind, controlled confirmatory efficacy trial of a novel, neuroplasticity-based computerized
cognitive remediation (nCCR) intervention for treatment resistant late-life major depressive disorder (LLD). We
developed nCCR to target cognitive control deficits (CCD), a behavioral expression of altered function of the
Research Domain Criteria (RDoC)-defined, cognitive control network (CCN). This novel intervention is
consistent with NIMH priorities to advance interventions informed by cognitive and affective neuroscience
(strategy 3.1) that can be disseminated to the community (strategy 3.3). In LLD, deficits in cognitive control
functions (CCD) are common, and disabling. We and others have documented that specific CCD, and their
underlying brain network abnormalities, are associated with poor response to antidepressants, relapse, and
increased risk for suicide. These deficits are mediated by the CCN, a frontoparietal circuit that comprises the
dorsolateral prefrontal cortex, dorsal anterior cingulate cortex, and posterior parietal cortex, as well as
projections to the ventromedial prefrontal cortex and subcortical structures, including the striatum.
The theory guiding neuroplasticity-based cognitive interventions is that network abnormalities associated
with negative disease-specific clinical outcomes can be altered through the induction of neuroplasticity (even in
the aging brain), resulting in enhanced functioning of the target network, and symptomatic improvements. The
methodology we employed is founded in basic animal science of induction of plasticity in the aging brain, and
it is translated into computer algorithms that deliver (1) increasingly challenging; (2) dynamic difficulty adjusted;
(3) attention demanding; and (4) immediately rewarding cognitive training designed to activate CCD associated
with poor clinical outcomes. We recently tested nCCR in three preliminary clinical trials.
Our preliminary data indicate that nCCR will likely engage our proposed target, CCD. Further, nCCR
appears to have more robust mood effects in participants who have pronounced CCD, while SSRI/SNRI-
treated patients are two times less likely to benefit. We designed nCCR to be: short (4-week dose), efficacious,
mobile (available via web), cost-effective (does not require an MD/PhD), with the potential for wide distribution,
easy adoptability, and extensibility to address this urgent, unmet therapeutic need in LLD. For these patients
there is currently no treatment that adequately addresses both mood and cognitive impairment. The data
produced by this proposal will allow us to study the relationship between CCD and changes in mood, and
compare these effects to a control condition in LLD participants who have failed first-line treatments. Further,
we propose a two-site, sufficiently powered trial to study our technology-facilitated parameters, as well as
implementation procedures in two large medical systems, which have great potential to inform future
interventions of this type and support scalability of mobile nCCR into “usual care” settings.

Public health relevance
We propose to test a neuroplasticity-based computerized cognitive remediation intervention (nCCR) (a non-invasive form of targeted brain training) against an active control intervention to improve cognitive control deficits (CCD) in patients with late life major depression (LLD) who have not responded to antidepressant treatment (SSRI/SNRI). CCD are indicative of abnormalities in the cognitive control network (CCN), a brain network whose degeneration is associated with poor clinical outcomes in LLD including, poor response to SSRI/SNRI antidepressants, severe course, relapse, disability, suicide and all-cause mortality. If successful at improving CCD and related cognitive deficits in LLD, nCCR has the potential to improve mood and cognitive impairments, and increase the number of LLD patients who are able to attain and sustain remission. nCCR is designed to be cost effective and easily disseminated and thus could reduce public health costs and have a wide-spread impact on disability and suffering in a group at high risk poor clinical outcomes